ENERGY COSTS OF ACTIVITIES OF DAILY LIFE

The energy cost in excess of maintenance energy expenditure at rest will be measured for simulated activities of daily life. Subjects will be selected to represent a wide range of weight and body compositions. The relationship between energy expenditure and weight or body composition will be investigated by regression analysis.